Cortical processing at the center-of-gaze

SUMMARY
Almost nothing is known about the mechanisms of vision at the center-of-gaze, and yet that
knowledge is fundamental to understanding how vision works. For example, our visual perception
seems to be at the resolution that is only achievable at the center-of-gaze (or "fovea"), with eye-
movements constantly redirecting the fovea to regions of interest. Thus, this knowledge of how
the primary visual cortex (V1) processes this information has obvious basic science relevance, as
well as potential clinical relevance. The proposed work overcomes myriad technical challenges to
provide the first detailed look at the how the foveal V1 processes visual information, using
recordings in the macaque monkey, the most common model of human trichromatic vision. The
work involves both methodological and intellectual innovation; it will be the product of a team
approach that unites scientists with the required computational and empirical expertise. Because
almost all knowledge of the visual system is based outside of the fovea, we hypothesize to discover
new mechanisms of visual processing dictated by the unique constraints of processing high-acuity
color vision.

Public health relevance
PROJECT NARRATIVE Almost nothing is known about the mechanisms of vision at the center-of-gaze, and yet that knowledge is fundamental to understanding how vision works. Here we will perform detailed measurements of how the cortex processes vision at the center-of-gaze using new experimental and computational approaches. We will gain insight into the how neurons represent high acuity vision and color, which is has both basic science and clinical relevance.